Research Education

The Research Education Component (REC) of the Massachusetts Alzheimer’s Disease Research Center
(MADRC) leads the Center’s efforts to develop junior investigators into future leaders in research on
Alzheimer’s disease and related disorders (ADRD) in service of the MADRC's broader theme of
understanding the drivers of clinical progression. The REC was established at the beginning of the
present funding cycle, building on extensive experience as investigators and educators and leveraging local
resources. We follow similar organizing principles as the MADRC as a whole--but all our aims are focused on
training. To contribute a formal training program, we recruit and select a diverse cohort of REC
Scholars (Aim 1a) and provide cross disciplinary training and mentorship (Aim 1b). To develop cutting-
edge training and networking through local rotations and partnerships, we provide training rotations
on intensive cutting-edge clinical and basic research methods (Aim 2a) and develop cross-institutional
partnerships to broaden training and enhance networking (Aim 2b). To diversify our trainees and
faculty, we partner with local programs to facilitate recruitment and training of trainees from groups
that are underrepresented in medicine (UiM, Aim 3a), invite and encourage diverse mentors and
lecturers for our trainees (Aim 3b), and participate in pathway programs to develop the diverse
research workforce of the future (Aim 3c). Building on existing funded clinical fellowships, T32s, K awards,
and other programs, we will select 5 funded REC Scholars and an additional 7-10 REC Affiliates, typically
fellows or junior faculty--clinician-scientists and basic/quantitative scientists--from diverse academic disciplines
for one-year REC training layered on top of their training or career development activities. Disciplinary and
racial and ethnic diversity will be a major emphasis of our recruitment efforts. We will provide multidisciplinary
mentorship, didactics, immersive experiences, career development activities (including a future-focused
leadership workshop series and general and ADRD-specific training in the responsible conduct of research); a
tailored methods training; and an individualized formal career development plan. We will offer an array of
methods training rotations for REC trainees and others, and develop cross-institutional partnerships with other
ADRCs and local programs for extended learning and cross-pollination of ideas across Centers, provide
networking opportunities, and enhance the diversity of our trainees. In parallel, we will work with the MADRC
as a whole to enhancing the diversity of our mentors and lecturers. Last, we will participate in institutional
pathway programs to support the long-term diversity of the biomedical research enterprise on ADRD.